Redefining and Improving Hypothyroidism Care Using Real-World Data

PROJECT SUMMARY/ABSTRACT
Hypothyroidism is a metabolic disorder that affects nearly 10% of the US population and directly contributes to
over $400 million in healthcare costs annually. The primary treatment is to replace low thyroid hormone levels
with levothyroxine (LT4) and normalize serum thyroid stimulating hormone (TSH). The TSH level provides
clinicians with a measure of disease control over the last 2 months. If the TSH level is above or below the
normal range, the clinician may adjust the LT4 dose and retest TSH. However, observational evidence
suggests that the test-and-adjust treatment approach is inadequate for many patients, as one-quarter to one-
half of patients experience uncontrolled TSH levels. Uncontrolled TSH levels cause systemic symptoms and
increase the risk of adverse cardiovascular (CV) outcomes. However, our understanding of the impact of
uncontrolled TSH levels on health outcomes is based on cross-sectional data and does not account for the
cumulative exposure of uncontrolled TSH levels over time. In Aim 1 of this proposal, using real-world clinical
data, the PI (Dr. Matthew Ettleson) will determine the association between cumulative TSH control and CV
outcomes in patients with LT4-treated hypothyroidism using longitudinal analysis methods. Given the high
frequency of uncontrolled TSH levels, strategies are also needed to improve the long-term management of
hypothyroidism. In other chronic diseases, machine learning (ML) approaches and clinical decision support
have been leveraged to individualize treatment and improve outcomes. In Aim 2, the PI will develop an ML
model to identify which patients are at high risk of uncontrolled TSH levels within the next year of LT4
treatment. In Aim 3, the PI will seek to improve clinical practice by designing and implementing a clinical
decision support system that identifies high risk patients, informs clinicians of monitoring gaps, and provides
best practice recommendations at the point of care. The results of these studies will be used to inform an R01
proposal that will examine the effectiveness of risk-based monitoring approaches and clinical decision support
to improve TSH control in LT4-treated patients. The purpose of this career development award is to support
the PI in his long-term career goal of becoming a nationally recognized, independent health services and
outcomes researcher with expertise in improving thyroid disease management. To meet his research and
career goals, the PI will acquire skills in the following training areas that complement the research aims: 1)
longitudinal analysis, 2) predictive modeling, 3) clinical informatics and implementation science, and 4)
complete the Master of Science in Public Health Sciences for Clinical Professionals degree. The PI will work
closely with his mentorship team, led by Dr. Neda Laiteerapong and Dr. Antonio Bianco, to meet the proposed
research and training goals. The project will take place at the University of Chicago, a world-renowned
institution with high-impact research programs in thyroid disease and health services and outcomes research.

Public health relevance
PROJECT NARRATIVE Hypothyroidism is a metabolic disorder that affects nearly 10% of the US population and directly contributes to over $400 million in healthcare costs annually. The primary research goals of this proposal are to redefine and improve hypothyroidism care using real-world data and clinical informatics interventions. To achieve these goals, I will determine the cumulative impact of disease control on patient outcomes, develop a machine learning model to predict disease control, and design and evaluate a clinical decision support system to assist clinicians in managing hypothyroidism.